Administrative Core

PROJECT SUMMARY – VDDRC ADMINISTRATIVE CORE
The overarching goal of the Administrative Core is to support the continuing development of the
VDDRC Research Base and to ensure responsiveness of the Research Cores to the needs of
VDDRC members and Pilot Project grant recipients. The administrative and scientific leadership of the
VDDRC is provided by the Director, Richard Peek, and the Associate Directors, Naji Abumrad and Keith
Wilson, and is augmented by the Scientific Advisory Board, composed of renowned internal and external
investigators, and by the Executive Committee, which is comprised of the Director, Associate Directors,
Core Directors, and Program Leaders. Two 0.5 FTE administrative assistants provide the necessary
support for day-to-day financial management and operations of the VDDRC. The Administrative Core
supports a Biostatistical Program directed by Dr. Tatsuki Koyama to assist pilot project applicants and
recipients as well as VDDRC members in clinical and basic research study design, data analysis, and
database management. An Enrichment Program co-directed by Dr. Abumrad, fosters new investigation
in digestive diseases research by supporting prominent scientists to present research seminars at
Vanderbilt, enhancing core utilization by addressing member research needs, and through an annual
retreat. The seminar series and the retreat provide opportunities for collaboration through scientific and
technical interactions between members and Core Directors. The Enrichment Program also supports
acquisition of new skills through the Enrichment Training (mini-sabbatical) Program. To train the next
generation of GI researchers, we created the VDDRC Academy of Investigators, a program in which
junior investigators acquire important career development tools. This component is directed by Dr.
Alyssa Hasty and co-directed by Dr. Lori Coburn, and will continue to receive $125,000 from Vanderbilt
over the next 5 years. The Academy will now oversee a new VDDRC Diversity Initiative supported by
both NIDDK and Vanderbilt with an overall goal of attracting, nurturing, and retaining underrepresented
minority investigators in digestive diseases research. The Administrative Core oversees the Pilot and
Feasibility Project Program, which has invested >$1.3M into investigator-initiated research in the
current funding period and is directed by Dr. Wilson. This program is designed to attract new and
seasoned investigators to pursue digestive diseases research and receives an additional $100,000
annually from Vanderbilt. New partnerships with Vanderbilt Centers have now been established to co-fund
additional content appropriate Pilots. Finally, there is now a new institutional commitment of $125,000 to
support an innovative Complementary Awards Program to provide funding to VDDRC members for non-
VDDRC Core services.